Nanofiber Scaffolds for Salivary Gland Regeneration

ABSTRACT
Although extracellular matrix (ECM) remodeling is a natural response to injury, excessive ECM deposition, or fibrosis,
limits regeneration, is a causative factor in hundreds of diseases, and leads to 40% of all deaths worldwide. Fibrosis
occurs in salivary glands (SG) of patients treated with radiation for head and neck cancers and in patients suffering from
the autoimmune disease, Sjögren’s Syndrome (SS). Despite the known inhibitory effects of fibrosis on tissue regeneration,
and involvement of fibrosis in disease, the mechanisms through which fibrosis develops in the salivary gland and leads to
dysfunction have not been explored. The stroma of salivary glands and other organs includes tissue-resident mesenchymal
stem cells (MSCs). MSCs have inherent anti-fibrotic and anti-inflammatory functions; however, in disease states tissue-
resident MSCs can undergo conversion into myofibroblasts (myo-FBs) and contribute to fibrosis. Therapeutic
transplantation of MSCs has been used to treat many inflammatory disorders, with the most common tissue source for
therapeutic MSCs being bone marrow (BM). Injection of BM-MSCs into non-obese diabetic (NOD) mice, a commonly
used mouse model for SS, showed decreased inflammation and some limited SG functional restoration; however, effects
were transient and the mechanisms leading to restored function remain unknown. Therapies that manipulate endogenous
or apply exogenous MSCs hold clinical promise for diseases involving fibrosis and salivary hypofunction. Mechanisms
through which tissue-resident MSCs and transplanted MSCs become fibrosis-generating myo-FBs in the SG are unknown;
however, in many tissues signaling by Gli1 is required. We hypothesize that tissue-resident MSCs that undergo
conversion to myo-FBs leading to fibrotic connective tissue exacerbating autoimmune disease and salivary dysfunction.
The objective of this proposal is to determine if modulation of tissue-resident MSCs can limit fibrosis, inflammation, and
restore gland function in injured and diseased salivary glands. We will address several important clinically relevant
questions in this proposal: 1) Does Gli1 signaling contribute to fibrosis in injured/diseased salivary glands? 2) Can tissue-
resident myo-FBs revert to a pro-regenerative MSC state and what are the associated genetic changes that demark this
conversion? 3) In a murine Sjögren’s Syndrome model, will limiting conversion of tissue-resident MSCs into myo-FBs
limit fibrosis, decrease disease progression, and facilitate functional restoration? The outcomes of our proposed study are
expected to improve scientific knowledge by revealing cellular mechanisms through which MSCs contribute to fibrosis in
SG. These findings will have a positive impact by identifying potential therapeutic targets. In addition, we will optimize
scaffold delivery systems for MSCs and anti-fibrotic pharmacologicals for reducing fibrosis and restoring function in
hypofunctioning salivary glands and other organs.

Public health relevance
NARRATIVE Most mammalian organs fail to regenerate and regain function following significant injury, which may be due to a healing response that repairs the injury but is non-productive for restoration of gland function. In this project we will define the contribution of the counterproductive wound healing response, known as fibrosis, in restoration of gland function after injury. Since fibrosis occurs in the poorly functioning salivary glands of patients subjected to therapeutic radiation for head and neck cancer and in glands of patients suffering from the autoimmune disease, Sjögren’s Syndrome, this work will provide possible therapeutic targets and methods for restoring function in these patients. This work may also provide new insights into new therapeutic options to stimulate regeneration in other diseases in which fibrosis limits restoration of gland function after injury.